Discovery to Cure Summer Program

This is a competitive renewal in support of the Discovery to Cure High School Internship Program (DTCHIP).
The Discovery to Cure High School Internship was established 15 years ago in order to offer an unprecedented
scientific and personal challenge to young students by pairing them with respected scientists and encouraging
and fostering their interest in the fields of science and medicine. The Program has been extremely successful.
Its impact on young scientists has been proven over the years, and with the support of NICHD/NIH, we have
been able to expand the program and increase the number of participating students. During the current funding
period (2012-2016), the DTCHIP has mentored 208 Scholars, 138 from minority or underprivileged areas. The
quality and relevance of the program are recognized by top universities, which take into consideration the
students' participation in the program for their selection. Top colleges and universities throughout the country,
including Yale University, have accepted the graduated high school Scholars from the program, with a record
number in their early action. This proposal is a continuation of this well-established, rigorous, step-wise,
research-training program. Our objective is to continue and expand our objective to provide, thought the
Discovery to Cure High School Internship Program high-quality research experience to qualified students,
undergraduates, and high school teachers and to expose them to the excitement and possibility of biomedical
research careers. Our specific aims are as follows:
Aim 1) To provide high school students with a rich intellectual and investigative environment. Interns
work in state-of-the-art laboratories, under the mentorship of a PI, post-doctorate or research assistant, learning
basic laboratory methods and techniques and producing an independent research project, which he or she
presents to mentors, faculty, and peers at the end of the Program.
Aim 2) To encourage scientific curiosity, cooperation and foster critical thinking. Interns develop their own
scientific projects, which will be further expanded during the academic year at their institution, encouraging them
to participate in National Science events.
As proven so far, the DTCHIP provides the Scholars with the training required to contribute in an active,
productive and significant way to the ongoing research within the laboratories that they are assigned. The data
generated by the Scholars has been incorporated into publications where they are co-authors, further
contributing to their academic careers.

Public health relevance
Our objective is to provide, through the Discovery to Cure High School Internship Program, high-quality research experience to qualified high school students, undergraduates and high school teachers and to expose them to the excitement and possibility of biomedical research careers. Our objectives are: to attract young students to careers in science; enhance the scientific experience of undergraduate students; and to enhance the skills of science teachers and enable them to become more effective in communicating the nature of the scientific process to their students.